Understanding and addressing sub-optimal responses to CAR T cell therapy for Multiple Myeloma

Candidate: Eric Smith, MD PhD, is an Assistant Attending on the Myeloma Service at Memorial Sloan
Kettering Cancer Center, and a post-doc in the lab of his proposed K08 mentor, Renier Brentjens, MD PhD. In
the Brentjens lab, Dr. Smith developed optimized fully human chimeric antigen receptor (CAR) vectors for the
treatment of multiple myeloma (MM). B cell maturation antigen (BCMA) targeted CAR T cells stemming from
his work are under clinical evaluation in four separate clinical trials, including a multi-institution phase I/II
registration study. G-protein-coupled receptor C5D (GPRC5D; a novel target he validated for the
immunotherapy of MM) targeted CAR T cells he developed are scheduled to enter clinical investigation in
12/2018. While response rates to BCMA targeted CAR T cell therapy are high, many patients go on to
relapse. Dr. Smith proposes to study mechanisms of CAR T cell relapse, with a focus on interactions in the
MM tumor microenvironment (TME) that may lead to sub-optimal responses, and evaluate novel CAR vectors
to enhance CAR T cell efficacy. In the course of carrying out this research, he plans to acquire the technical
and intellectual skills and experience required to transition successfully to independent laboratory investigator.
Career Development Plan: Dr. Smith has a detailed career development plan based on mentorship, an
advisory committee, collaborators, and select course work. Dr. Brentjens, his primary mentor, will continue to
provide training and development relating to CAR T cell therapy and T cell biology. His advisory committee
has complementary expertise that will enhance his training and development. All advisors have extensive
expertise on advanced mouse models of cancer. Dr. Wolchok is an expert on T cell immunology; Dr. Wendel
has significant experience with CRISPR; Dr. Abdul-Wahab is a leader in genetics of hematologic malignancies,
including gene expression analyses; and Dr. Dhodapkar has spent his career studying the MM
microenvironment. Additional informal interactions and formal course work will contribute to Dr. Smith's
development in the above areas as well as CyTOF data analysis and biostatistics. Grant writing, presentation,
and leadership skills will be enhanced throughout the grant period. These experiences will lead to the
establishment of an independent lab group focused on adoptive cellular therapy and an R01 application.
Research Plan: In aim 1, Dr. Smith will address target antigen loss mediated relapse by comparing multiple
BCMA/GPRC5D dual-targeted CAR T cell strategies in a model of antigen escape to determine an optimal
dual-targeting approach. Aim 2, focuses on understanding antigen positive relapse in the setting of the human
MM TME through use of the multiply-transgenic humanized MISTRG6 murine model that uniquely supports
MM cells and associated bone marrow immune cells, as well as through the study of marrow samples from
CAR T cell treated patients. He will assess rational armored CAR approaches that may overcome MM TME
immune suppression in order to enhance the durability of response to CAR T cell therapy in advanced MM.

Public health relevance
PROJECT NARRATIVE CAR T cell therapy targeting BCMA for advanced multiple myeloma (MM) leads to a high overall response rate, however, with durability limited in many patients mediated by target antigen loss or lack of CAR T cell expansion/functional persistence. Our work aims to better understand mechanisms of relapse post-CAR T cell therapy in the setting of the MM tumor microenvironment by studying patient marrow immune cells in a humanized mouse model and samples from MM patients treated on CAR T cell clinical trials. We will compare novel CAR T cell strategies targeting dual-antigens to mitigate antigen escape, and “armored” CAR T cell strategies to mitigate MM tumor microenvironment immune suppression.